High resolution 3D dental X-ray imaging system with low dose and low cost

? DESCRIPTION (provided by applicant): The need to reliably detect proximal and occlusal caries remains a high oral health priority. Caries affect millions of Americans and, when undetected, could evolve into more serious conditions that may require large restorations, endodontic treatment, or extraction. The caries detection sensitivity using existing dental image modalities, 2D intra-oral imaging and 3D cone beam computed tomography (CBCT) imaging, is low. We propose to develop and manufacture a mobile and low cost intraoral tomosynthesis (IOT) system capable of detecting caries and tooth fractures with higher sensitivity and lower dose compared to CBCT. The system is based on the unique carbon nanotube X-ray source array technology invented by our team. Its introduction to the market is expected to have significant impact in improving American's dental health, while reducing overall radiation dose to the population.

Public health relevance
PUBLIC HEALTH RELEVANCE: We propose to develop and manufacture a portable and low cost imaging system capable of detecting cavities and tooth fractures with low radiation dose. This would allow dentists to preserve tooth structure, save teeth from extraction, and prevent future pain to the patient. The system is based on the unique X-ray source array technology invented by our team, its introduction into the market is expected to have a significant impact on American's dental health, while reducing overall radiation dose to the population.